SOMATROPIN THERAPY IN HYPOPITUITARY CHILDREN--A MULTICENTER TRIAL

Somatropin (natural sequence hGH) is used in children with growth hormone deficiency to evaluate their responses in promoting linear growth and to determine the safety of Somatropin. ("D" protocol)